Mid-Atlantic Microbial Pathogenesis Meeting

ABSTRACT
The Mid-Atlantic Microbial Pathogenesis Meeting (MAMPM) was founded in 2003 and is a biennial
meeting that will be held in early February 2025 at Wintergreen Resort and Conference Center near
Charlottesville, Virginia. The purpose of MAMPM is to foster communication and collaboration among scientists
engaged in microbial pathogenesis research in the Mid-Atlantic Region (North Carolina, Virginia, Maryland,
The District of Columbia, West Virginia, and Delaware). Numerous NIH/NIAID-funded investigators studying
the virulence mechanisms of pathogens of importance to human health are in this geographic region and have
participated in multiple MAMPMs. However, MAMPM attracts scientists both from within and outside the Mid-
Atlantic region – on average for the last 5 meetings, 80% of the 190 attendees were from the Mid-Atlantic
region, while 20% traveled from at least 8 states outside the region per meeting.
MAMPM’s primary goal is to provide students, postdoctoral fellows, and junior faculty with the opportunity to
present their work in a collegial, yet scientifically rigorous environment. As such, MAMPM is a formative
experience for young scientists’ professional development, which remains one of the most appealing and
positively evaluated aspects of this conference. MAMPM will consist of four scientific sessions over three days.
Each session will feature an invited keynote speaker and talks by graduate students, postdoctoral fellows, and
a limited number of junior principal investigators (selected from the submitted abstracts by the Scientific
Program Committee). Two highly interactive poster sessions will also be held to provide the opportunity for all
participants to present and discuss their work face-to-face. For MAMPM 2025, Drs. Sean Crosson (Michigan
State Univ.), Michael Jonhson (Univ. Arizona), Carol Kumamoto (Tufts Univ.), and Christina Stallings
(Washington Univ. St. Louis) have agreed to be Keynote Speakers. The conference will be publicized
through advertisements in professional publications and local American Society for Microbiology branches,
social media posts, and direct electronic mailings to relevant departments at academic institutions and
government and private laboratories within the region.
MAMPM remains committed to ensuring a balanced representation of women, underrepresented minorities,
and persons of disability in the leadership, conference participation, and as speakers, including the keynote
speakers. The conference will also feature a diversity-focused session each year. For MAMPM 2025, we
will hold a mentoring workshop lead by Keynote Speaker Dr. Johnna Frierson (Duke Univ.), which will
highlight mentoring strategies in increase inclusivity in STEM. In addition, MAMPM specifically includes
“Dine with a Keynote” opportunities for trainees to discuss professional development issues and promote
scientific networking.

Public health relevance
PROJECT NARRATIVE The purpose of the Mid-Atlantic Microbial Pathogenesis Meeting (MAMPM) is to foster communication and collaboration between scientists engaged in research focused on disease-causing microbes in this geographic region. The goal of the organizers is to assemble a high-quality scientific program to attract outstanding principal investigators along with their undergraduates, laboratory technicians, graduate students, post-doctoral fellows, and junior faculty. This meeting will provide an opportunity for junior scientists to present their work to a knowledgeable audience in a supportive and collegial environment.